TRiP resources for modeling human disease

PROJECT SUMMARY / ABSTRACT
This application requests continued funding for the TRiP, a highly successful in vivo Drosophila functional
genomics platform at Harvard Medical School. To date we have generated more than 17,000 RNAi and
CRISPR fly stocks for the research community. We propose to expand the TRiP resource of versatile and
transformative transgenic tools for gene activation, repression and genome engineering. The goals of this
resource, focused on the 3017 fly genes orthologous to genes known or suspected to be associated with
human diseases, are to: (1) generate shRNA fly stocks for RNAi that address remaining gaps in the collection,
such as genes not yet covered or reagents identified by the community as ineffective; (2) generate sgRNA
stocks for CRISPR knock out (CRISPRko) and CRISPR activation (CRISPRa); (3) Build a toolkit of reagents
that combine GAL4/UAS and a second binary expression system (LexA/lexAop or QF/QUAS) to facilitate RNAi
and/or CRISPR control of gene expression in two different tissues independently; and (5) evaluate whole
animal as well as tissue-specific loss-of-function (LOF) and gain-of-function (GOF) phenotypes associated with
the new lines and curate information on the quality of individual RNAi and sgRNA lines in our “RSVP Plus”
phenotype database. The result of these efforts will be a tremendous resource of fly stocks, distributed to the
community by the Bloomington Drosophila Stock Center, which will allow researchers to easily knock down,
knock out, or activate genes covered by the collection. When combined with the wide array of GAL4 lines, and
our proposed new collection of LexA/QF lines, this genetic toolkit will allow researchers to modulate gene
expression in any given stage and in multiple tissues simultaneously.

Public health relevance
PROJECT NARRATIVE This project is to expand the TRiP resource of Drosophila transgenic lines relevant to human diseases and develop tools to make them even more useful and accessible to the research community. The resources we build contribute to the knowledge of Drosophila and help researchers develop Drosophila models of human diseases, and as such are relevant to almost all NIH institutes and relevant in particular to diseases.